Intracellular delivery of DNA-editing proteins by viscoelastic cell stretching

Summary/Abstract
Immune cell therapies are a powerful new class of “living medicines” for treating cancer and other diseases, but
producing them remains laborious, inefficient, and slow. The chief bottleneck is the challenge of making accurate
changes to the DNA of extremely large numbers—often billions—of human cells ex vivo. Gene editing with
CRISPR-Cas9 is much more precise than lentiviral or retroviral vectors, but it remains difficult to deliver controlled
amounts of the Cas9 endonuclease into human cells, particularly immune cells. A promising approach is to
momentarily disrupt the plasma membrane, allowing direct transport of DNA-editing proteins into the cytosol.
However, current & emerging nonviral delivery methods are nonuniform, damaging to cells, and too slow for
clinical applications that require billions of cells. Therefore, the research objective of this proposal is to develop
a very fast microfluidic method of permeabilizing the plasma membrane to facilitate efficient delivery of DNA-
editing proteins. The central innovation is to use viscoelastic fluid forces to stretch the plasma membrane without
cells touching any surfaces. As a result, this “contactless” approach is efficient, gentle, robust, and extraordinarily
fast—exceeding 100 million cells per minute in a single microchannel. The K99 phase of the project will focus
on developing this technology for efficient gene editing of T cells with CRISPR, to address the main bottleneck
in T cell engineering. In Aim 1, we will develop viscoelastic stretching for ribonucleoprotein delivery and allogenic
T cell engineering at one billion cells per minute, and we will characterize the biological effects of cell stretching
on T cells. In Aim 2, we will use this method to generate allogenic chimeric antigen receptor (CAR) T cells from
primary T cells, and assay their anti-tumor potency in vitro. In the R00 phase, viscoelastic cell stretching will be
developed into a high throughput “cell surgery” platform for directly transplanting exogenous proteins and other
nanoscale cargoes into the cytosol, towards the long-term goal of increasing the safety, accuracy, and efficiency
of gene editing in human cells. Building upon the knowledge, skills, and technologies gained during the K99
phase, Aim 3 will focus on delivering DNA repair factors such as Rad52 in protein form for the first time, to
temporarily increase the frequency of homology-directed repair and thereby safely increase the efficiency of
precision gene editing with CRISPR. The training objective of this project is to provide Dr. Sevenler—who has
a background in biomedical engineering—with additional scientific training from leading experts in microfluidics
(Dr. Toner, lead mentor, MGH/HMS), immunology (Dr. Yarmush, co-mentor, MGH/HMS), gene & drug delivery
(Dr. Bhatia, MIT), and T cell engineering (Dr. Maus, MGH/HMS, Dr. Choi, MGH/HMS and Dr. Ritz, DFCI/HMS).
This additional training will prepare Dr. Sevenler to lead an independent research program in biomedical
engineering focused on improved methods of reading and writing the molecular information of life.

Public health relevance
Project Narrative Gene editing systems such as CRISPR are useful for developing immune cell therapies, but clinical applications frequently require processing billions of cells outside the body and current methods are not able to directly deliver DNA-editing proteins into large numbers of cells. The proposed project will develop a very fast method of stretching cell membranes to create temporary pores, facilitating the delivery of proteins which cut DNA and control DNA repair. This nonviral approach of quickly delivering biomolecules into billions of human immune cells will be valuable for efficiently producing immune cell therapies at clinical scales.